Telluride Science Research Meeting on Frontiers in Biomagnetic Particles IV

? DESCRIPTION (provided by applicant): This proposal seeks support for travel awards for six graduate students and postdocs (with at least four reserved for minorities/underrepresented groups) to attend the Telluride Science Research Center meeting (TSRC) on Frontiers in BioMagnetic Particles IV, Telluride, CO June 23-26, 2015. These travel awards will greatly encourage diverse participation and networking in this highly interdisciplinary and rapidly growing field. Magnetic particles are an enabling technology for a wide variety of biomedical and functional materials research relevant to biomedical imaging, and cancer therapy and detection applications. Magnetic particles provide a unique handle to manipulate and sense nanostructures. Applications include magnetically guided drug delivery, magnetic hyperthermia, cell separations, and biomedical imaging via Magnetic Resonance Imaging (MRI), Magnetic Particle Imaging (MPI), and magnetophoretic optical coherence tomography contrast agents. Because this field benefits especially well from cross-fertilization of ideas from chemistry, biology, physics, and engineering, is our goal to create a technical and social environment in which participants from diverse disciplines can discuss trends in research and form collaborations. In order to encourage discussion, we have scheduled 20 minute panels of speakers at the end of each of seven sessions. To make sure women and unrepresented minorities are active participants in this discussion, we will have at least 50% women and minorities as session chairs leading these discussions. The symposium builds upon three successful symposia hosted by the PIs in Clemson SC (2009), Chareleston SC (2011), and Telluride SC (2013). The scientific symposium will take place June 23-26 in Telluride, CO under the umbrella of the Telluride Science Research Center. The goal will be to help participants build lasting, sustainable partnerships with national and international collaborators.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal seeks support for travel awards for six graduate students and postdocs (with at least four reserved for minorities/underrepresented groups) to attend the Telluride Science Research Center meeting (TSRC) on "Frontiers in BioMagnetic Particles IV," Telluride, CO June 23-26, 2015. These travel awards are relevant to public health because they encourage diverse participation and collaboration in developing magnetic nanoparticles for novel bioimaging and bioengineering applications, as well cancer detection/therapy applications.